Discordant transcriptional regulation of gluconeogenic and lipogenic gene expression

Abstract
Dysregulated glucose and lipid metabolism are hallmarks of insulin resistance and type 2 diabetes. In the
liver, this is manifested as the inability of insulin to suppress hepatic glucose output, while de novo lipogenesis
remains elevated even in the fasted state but is still capable of displaying an insulin-stimulated increase. The
inability of insulin to suppress hepatic glucose output while activating de novo lipogenesis has been referred to
as selective insulin resistance. The acute regulation of both gluconeogenesis and de novo lipogenesis primarily
results from rapid changes in allosteric regulation, however, in chronic states such as insulin resistance and
type 2 diabetes there are marked changes in gluconeogenic and lipogenic gene expression. We have obtained
preliminary data indicating that the prototypical lipogenic genes (i.e. FASN, SCD1) are primarily regulated by
transcription initiation whereas gluconeogenic genes (i.e.: PCK1, G6Pc) are primarily regulated at the level of
transcriptional elongation. During diet induced hepatic insulin resistance, the elongation factor Spt5 is
functionally dysregulated thereby increasing gluconeogenic gene expression in the fed state. In addition, using
single cell RNAseq we have identified the differential engagement of different hepatocyte subsets during the
fasting/feeding cycle that are also altered during the development of hepatocyte insulin resistance. Based upon
these data, we propose two specific aims to examine several novel molecular and cellular mechanisms that
are important regulatory components of normal physiologic hepatocyte lipogenic and gluconeogenic gene
expression that are subsequently dysregulated during diet-induced insulin resistance. Specifically, we use 1)
ChIP-Seq to determine the changes in various initiation and elongation factors in their DNA occupancy
binding, 2) ATAC-Seq to determine chromatin organization, and 3) ChRO-Seq to directly measure the
rates of transcription across gene bodies. These analyses of total hepatocyte function will be
complemented with single cell molecular analyses that include 1) single cell RNA-Seq to directly determine
differential function of hepatocyte subsets, 2) single cell ATAC-Seq for individual hepatocyte
chromatin organization changes, and 3) single molecule FISH to assess individual cellular
transcriptional activity and identification of their anatomical zonation. These approaches will allow us to
determine the molecular mechanisms responsible for the activation of transcriptional initiation and elongation
between lipogenic and gluconeogenic gene expression, and will expand our understanding of the individual
hepatocyte cellular responses that account for these changes in under normal fasting/feeding states and in
diet-induced liver insulin resistance.

Public health relevance
Narrative: In human and rodent models of Insulin resistance, the regulation of gluconeogenesis is altered such that hepatic glucose production is enhanced in the fasted state with reduced suppression in the fed state. In parallel, hepatic de novo lipogenesis is elevated in fasted state and further increased in the fed state. The inability of insulin to suppress hepatic glucose output but still to activated de novo lipogenesis has been referred to as selective insulin resistance. To understand the long-term epi- genetic changes responsible for the dysregulation in the liver, we are examining the basic transcriptional events that regulate gluconeogenic and lipogenic genes in normal and insulin resistant states through modulation of RNA Polymerase II. In this proposal we will use several high-end sequencing approaches that include ChRO-Seq, ChIP-Seq, ATAC-Seq, single cell RNA-Seq and single cell ATAC-Seq couple with single molecule FISH analyses.